Methods for Integrative Genomic Data Analysis

Abstract The broad, long-term objective of this project concerns the development of novel statistical methods, theory and computational tools for statistical modeling of large-scale multiple high-dimensional genomic data motivated by important biological questions and experiments. New high-throughput technologies and next generation se- quencing are generating various types of very high-dimensional genetics, genomic, epigenomics, metabolomics data in order to obtain an integrative understanding of various complex phenotypes. As the types and complexity of the data increase and as the questions being addressed become more sophisticated, statistical methods that can both integrate these genomic data and incorporate information about gene function and pathways are required in order to draw valid statistical and biological inferences. The speci c aims of the current project are to develop new statistical models and methods for causal integrative analysis of eQTL data with genome wide genetic association data (GWAS) in order to identify the possible causal genes and pathways for disease phenotypes. Motivated by analysis of diverse genomic data, the rst aim is to develop novel causal mediation analysis methods to identify the genes that mediate the e ects of genetic variants on disease phenotypes by constructing gene regulatory networks based on eQTL data. Aim 2 is to develop high-dimensional instrumental variables (HDIV) regression models in order to identify the phenotype-causing genes using eQTLs as possible instrumental variables. Aims 3 develops methods for estimating the genetic relatedness between disease phenotype and gene expressions in order to iden- tify the possible disease causing genes and biological pathways. Finally, Aim 4 is to develop statistical methods that can e ectively integrate GTEx data with GWAS association summary statistics in order to identify possible causal disease genes and pathways. These methods hinge on novel integration of methods for multiple related high-dimensional regressions and high-dimensional causal inference. The new methods can be applied to di erent types of genomic data and will ideally help facilitate the identi cation of genes and their complex interactions as well as the biological pathways underlying various complex human diseases. The work proposed here will con- tribute statistical methodology and theory for modeling high-dimensional genomic data and to studying complex phenotypes and biological systems and o er insights into each of the biological areas represented by the various data sets, including Alzheimer's disease, cardiometabolic syndrome, and chronic kidney disease. All algorithms and software tools developed under this grant and detailed documentation will be made available free-of-charge to interested researchers.

Public health relevance
Project Narrative and Relevance to Public Health This project aims to develop powerful statistical and computational methods for integrative analysis of diverse genomic data. The novel statistical methods are expected to gain more insights into how genomic perturbation and pathways dysfunction can lead to development of complex diseases such as Alzheimer's disease, cardiometabolic syndrome, and chronic kidney disease.